INVESTIGATION OF NONTUBERCULOUS MYCOBACTERIA IN PATIENTS WITH CYSTIC FIBROSIS

The objective of this multicenter investigation is to determine the impact of nontuberculous mycobacterium on the natural course of cystic fibrosis lung disease. Specifically, what is th eprevalence of these organisms? and do these patients with NTM have a more rapid decline than those without? The study requires collection of sputum samples over al1 year period for mycobacterium on 30-35 patients.